Intracellular functions and mechanisms of alphavirus ion channel 6K

Mosquito-borne alphaviruses such as chikungunya, Mayaro, and Eastern equine encephalitis viruses cause high
morbidity and mortality in their mammalian hosts. Alphaviruses are globally distributed arthropod-borne viruses
that are enzootic in nature with the potential to disseminate to new geographical regions due to vector
adaptations causing new outbreaks. A 2019 outbreak of 38 human cases of Eastern equine encephalitis virus
occurred in the United States, raising concerns about its reemergence. In 2005–2006, a chikungunya outbreak
started in the Indian Ocean Island of Réunion had spread around the world, infecting millions of people.
Chikungunya fever is characterized by debilitating joint pain that can last up to 2–3 years, causing arthritis-like
conditions. No effective antiviral strategies or vaccines are available against any of these pathogens. Studying
these viruses to gain a molecular understanding of their lifecycle is essential to discovering novel targets for
therapeutic intervention. Specifically, the poorly understood intracellular mechanisms that drive alphavirus
assembly and budding represent promising antiviral targets. We reported for the first time that the alphavirus-
encoded ion channel protein 6K plays an essential part in virus budding by enabling the formation of cytopathic
vacuoles-II and envelope spike protein transport to the plasma membrane. The defects due to the deletion of 6K
can be restored to varying levels by the expression of a functional HIV-1 Vpu and influenza A virus M2 ion
channel. We also demonstrated that ion channel inhibitors could be utilized as antivirals. Building on these
observations, in Aim 1, we will characterize chikungunya and Sindbis virus 6K ion channels and their activity by
reverse genetics, transport assays in proteoliposomes and fractionated intracellular membrane vesicles, and
live-confocal imaging of virus-infected cells with ion-specific fluorescent probes. In Aim 2, by expressing virus-
encoded ion channels, including the SARS-CoV-2 E protein in cells and from an alphavirus, we will determine if
ion channel-based Golgi remodeling is a standard mechanism used by enveloped RNA viruses for membrane
modification and efficient virus budding. With new reverse genetics tools and CRISPR-Cas9 methods, we will
investigate the functional involvement of host-encoded ion channels in alphavirus budding. By completing these
aims, we will define a novel mechanism by which ion channel proteins modify the secretory pathway for virus
budding and how this process can be exploited as an antiviral target. We will also generate new reverse genetics
tools that will be useful to the scientific community. The critical knowledge gaps we will address are 1) what are
the ions transported by alphavirus 6K? 2) how does 6K participate in virus budding? and 3) an understanding of
a general mechanism involving virus and host ion channels utilized by alphaviruses for efficient budding.

Public health relevance
Mosquito-borne alphaviruses, such as chikungunya virus, causing debilitating arthritis, and Eastern equine encephalitis virus, causing fatal encephalitis, are becoming endemic in the Americas with no available vaccines or antivirals. Using reverse genetics, cutting-edge microscopy, and molecular biology approaches, we will explore the functional role of alphavirus ion channel 6K in affecting intracellular ion homeostasis, membrane modifications, and virus budding. Identifying the host proteins in the secretory pathway modifying the Golgi facilitating virus budding will provide targets for antiviral strategies.